Core 01: Professional Development Core

Project Summary: Professional Development Core
Louisiana citizens experience significantly higher rates of cardiovascular disease, diabetes/obesity, and
cancer with significant disparities between subgroups of citizens. Unfortunately, there are
not adequate numbers of investigators proficient in Clinical and Translational Research to address and diminish
these health disparities. The overall objective of the Louisiana Clinical and Translational Science (LA CaTS)
Center Professional Development Core (PD Core) is to educate and train early-career and senior academic
faculty state-wide to pursue clinical/translational research focused on improving health outcomes and reducing
health disparities in Louisiana. The PD Core provides a degree-granting training program for early-career faculty
(Scholars), a Masters in Clinical Research (MSCR), which provides mentorship, and access to a variety of
educational research resources to aid Scholars from different health professions throughout the state. The PD
Core research plans are based on the following specific aims: (1) further develop and refine programs that
support clinical/translational research training, mentoring, and career development, and build a network of early
career trainees that specifically supports under-represented groups in the biomedical workforce, (2) create,
provide, and coordinate accessible resources to aid faculty and trainees in developing, initiating, executing,
analyzing, and disseminating clinical/translational research and (3) facilitate and enhance Equity, Diversity, and
Inclusion (EDI) initiatives and training within our multi-institution statewide research community. The PD Core
will implement the research plan by providing an academic “home”, the Roadmap Scholar Program, a 75%
protected-time training period over two years that provides clinical and translational research training tailored
to Scholars with a wider range of research experience (e.g., students to postdoctoral fellows) and from different
professional disciplines (e.g., medicine, nursing, public health, social work). This cross-institutional structured
approach has been developed to include collaborating LA CaTS institutions throughout the state of
Louisiana. The PD Core plans to provide training and research resources, including courses in the
MSCR curriculum on-site and by Distance Learning, access to a centralized clinical trial enrollment center, the
state-wide virtual biorepository resource, and “team science” projects focused on health disparities and disease
outcomes which promote research team collaborations. Distance Learning is key in providing Scholars access
to all PD Core resources; therefore, a centralized compendium of MSCR courses and research tool kits will be
provided via an asynchronous system. Overall, the PD Core intends to recruit, educate, and train Scholars from
various health care disciplines and underrepresented groups (including a new scholar position specifically for
individuals from underrepresented groups), in clinical and translational research focused on diseases with high
rates of health disparities to improve health outcomes that negatively affect the citizens of Louisiana.